Feasibility study of a chaplain-delivered compassion intervention to improve psychological safety among interprofessional healthcare teams

Project Summary/Abstract:
Healthcare provider burnout is pervasive in oncology, and it imparts harm to providers and patients, increases
healthcare and workforce disparities, and exacerbates projected physician and nursing shortages. Although
burnout is primarily caused by organizational stressors, supportive and cooperative interdisciplinary teams
foster psychological safety and are protective against burnout. For this reason, interventions to improve
burnout require organization-directed approaches that address team dynamics and working environment (as
opposed to only focusing on individual resilience). Although there has been a multitude of small studies
investigating several interventions to prevent burnout, the evidence base remains extremely low due to the
poor quality of data and measurement approaches. As a first step to address the critical and unmet need for
evidence-based, acceptable, and scalable team-based interventions to improve burnout, we developed
Compassion Centered Spiritual Health Team Intervention (CCSH-TI), which includes mindfulness and
compassion-based approaches to bolster compassion for self and others and to improve psychological safety
and team civility. CCSH-TI is delivered by hospital chaplains who comprise a well-established and highly
acceptable non-sectarian clinical service present in nearly two-thirds of all US hospitals and trained to provide
emotional, psychosocial, and spiritual care to a broad range of patients and staff. The current proposal will use
a phase 1 clustered randomized, wait-list controlled, and mixed-method study to (1) examine the feasibility and
acceptability of CCSH-TI and (2) develop and validate a novel, low-burden ambulatory assessment “toolkit” to
improve the measurement of psychological safety and burnout. Employees (n = 80; nurses, advanced practice
providers (APPs), physicians, staff) working at an NCI-designated Comprehensive Cancer Center will be
randomized by team to CCSH-TI or wait-list. We will evaluate CCSH-TI feasibility (accrual, retention, CCSH-TI
attendance) and acceptability (satisfaction, credibility, perceived benefit). Focus groups will identify contextual
determinants of feasibility, acceptability, and implementation success. At pre/post-intervention and 12-week
follow-up, we will conduct 3-day ambulatory assessments: (1) Ecological Momentary Assessments (EMA) of
social connection, incivility, and burnout; and (2) Electronically Activated Recorder (EAR), a method of
periodically and unobtrusively sampling acoustic observations that has been validated and established outside
the healthcare environment. We will develop and validate EAR behavioral codebooks tailored to the healthcare
environment to quantify behavioral indices of psychological safety, incivility, and interprofessional teamwork.
This proposal is an innovative and ‘real world’ approach to increase access, equity, and inclusion of burnout
prevention and mitigation among all healthcare providers and that improves scientific rigor of research on
burnout by developing a novel, objective, low-burden assessment toolkit.

Public health relevance
Project Narrative Burnout is pervasive in oncology, imparting harm to both providers and patients, increasing healthcare and workforce disparities, and exacerbating projected physician and nursing shortages. To address the critical and unmet need for evidence-based, acceptable, and scalable interventions to improve burnout, this application will evaluate the feasibility and acceptability of a novel team-based intervention that includes mindfulness and compassion-based approaches and is delivered by hospital chaplains embedded within the interprofessional team. It will also develop and validate a low-burden, objective, and embedded ambulatory assessment “toolkit” to identify interpersonal and objective behavioral indices that can be used to improve research rigor and ultimately expand the evidence-base for effective approaches to improve provider well-being and address the needs of the 21st century healthcare workforce.